Investigating Molecular Mechanisms of Alternating Hemiplegia of Childhood Using C. elegans Models

PROJECT SUMMARY/ABSTRACT
This proposal addresses fundamental questions about Na+, K+ ATPase function both in wild-type animals
and in a new C. elegans model for a rare disease called Alternating Hemiplegia of Childhood (AHC). AHC is one
of many diseases caused by dominant mutations in ATP1A3, a Na+, K+ ATPase. It is unknown how mutations in
ATP1A3 perturb cellular function, leading to disease.
I propose a novel hypothesis to explain AHC pathophysiology: defective ATP1A3 upregulates other P-type
ATPases that compete for β subunits; β is expressed at limited levels and essential for ATPase function. I
rigorously test this hypothesis in vivo using C. elegans models of AHC that I have developed.
I created the first C. elegans models of AHC by direct CRISPR/Cas9-based editing of patient missense
mutations into eat-6, the C. elegans ortholog of ATP1A3. Heterozygous AHC model animals have dominant
neuromuscular junction (NMJ) defects, unlike heterozygous eat-6 null animals. Therefore, AHC defects are
caused by a mechanism other than simple loss of ATPase activity. In Aim 1, I use the C. elegans models of AHC
to determine where wild-type and AHC model EAT-6 are required for normal and impaired NMJ function. In Aim
2, I determine if AHC patient mutations upregulate other P-type ATPases such as CATP-2 and if this contributes
to NMJ defects in AHC model animals. In Aim 3, I determine which β subunits interact with EAT-6 and test if β
is a limiting factor. This information is essential for future studies that delineate the cellular mechanisms perturbed
in AHC and investigate targets for therapy development.
I will complete this fellowship at Brown University in the Molecular Biology, Cell Biology, and Biochemistry
Graduate Program. Institutional and departmental resources strongly support my training goals. I will learn new
genetic and biochemical techniques such as determining where gene function is required in a live animal using
inducible gene expression, analyzing gene expression at the RNA and protein level, and testing protein
interactions based on pull down assays. Additionally, I will dedicate time and effort to professional development
and networking, teaching, and mentoring to become a strong candidate for a career in academia.

Public health relevance
PROJECT NARRATIVE Mutations in ATP1A3, a Na+, K+ ATPase, cause Alternating Hemiplegia of Childhood (AHC) through an unknown mechanism. In this proposal, I use C. elegans as a model organism to investigate properties of the Na+, K+ ATPase and determine how AHC patient mutations impair normal function. Completion of this project will provide foundational information for future studies that delineate the cellular mechanisms perturbed in AHC and investigate targets for therapy development.